Investigating autophagic degradation of tau mediated by polyubiquitination

Investigating autophagic degradation of tau mediated by polyubiquitination
Aberrant degradation and accumulation of tau in human brains is intimately connected to the
development of Alzheimer’s disease (AD). Attentions are now directed to the cellular pathways responsible for
the clearance of tau from neuronal cells, particularly through the autophagy-lysosome pathway. K63-linked
polyubiquitination of tau is intimately involved in the early stage of autophagic degradation of tau. Compared to
the better studied proteasomal degradation of tau, the recognition of tau by the autophagic machinery and the
subsequent degradation by lysosome is poorly understood. Mechanistic details and in-depth biochemical
characterization of the individual players and steps in this process are lacking. How the K63-linked
polyubiquitination of tau mediates its autophagic degradation is largely unknown. Moreover, our understanding
of tau deubiquitination and its role in regulating tau homeostasis is still very limited. We will address these
unanswered questions using K63-polyUb-tau probes generated using a semi-synthetic approach to capture and
identify cognate autophagic receptors and deubiquitinases that are responsible for modulation of the autophagic
degradation of tau. Our findings will unveil new biology in this cellular process and provide potential new targets
for pharmacological intervention of AD.

Public health relevance
Amyloid proteins such as tau is intimately involved in Alzheimer’s disease (AD) pathology. Tau is often observed in postmortem AD brains as neurofibrillary tangles (NFTs). It is believed that aberrant accumulation of tau in brains is closely connected with development of AD and tauopathies. It is now known that autophagy plays a crucial role in the cellular degradation of tau. Modulating tau degradation in brain may present therapeutic benefit to AD. In this application we propose to investigate how polyubiquitination mediates the autophagic degradation of tau in humans.